Deciphering the functional role of actin-spectrin-based membrane skeleton in subcellular compartmentalization of signaling proteins and cell signal transduction

Project Summary/Abstract:
Receptor tyrosine kinases (RTKs), G-protein-coupled receptors (GPCRs), and cell adhesion molecules (CAMs)
are three major families of cell surface proteins in all eukaryotic cells, and together represent the primary first
responders for cells to respond an extracellular stimulus and initiates a variety of signaling pathways to
subsequently regulate cell proliferation and differentiation, promote cell survival, and modulate cellular
metabolism and cell-to-cell communication. Mutations affecting these signaling pathways result in many human
syndromes and diseases, such as various types of neurodegenerative disorders and cancer. The clinical
importance of these signaling proteins has motivated the development of targeted therapies designed to block
the activation of the membrane receptors and the downstream signal transduction. Increasing evidence has
suggested that there is significant signaling crosstalk among these three membrane protein families at the
plasma membrane level and these proteins can form highly organized membrane micro- or nano-clusters with
unique biochemical and biophysical properties, dictating the signaling outcome. However, the molecular
mechanisms by which how such crosstalk and compartmentalization of membrane-associated signaling proteins
are initiated and maintained to modulate the sensitivity and specificity of the downstream signaling remain largely
elusive. Our recent discovery of a newly identified actin-spectrin-based membrane-associated periodic skeleton
(MPS) structure being a signaling platform for RTK transactivation by GPCRs and CAMs in neurons provides
molecular insights into how the cooperative action among these cell surface proteins can be coordinated to give
rise to the downstream signaling. The objective of this proposal is to combine super-resolution imaging, cell and
molecular biology tools, and mass spectrometry analyses, to investigate the distinctively physical molecular
mechanisms responsible for the MPS-mediated cell signaling, by identifying the key molecular interactions
responsible for the MPS-dependent assembly and disassembly of the signaling protein clusters (i.e., signaling
protein complexes) and examining the roles of liquid-liquid phase separation, receptor endocytosis, and contact
sites between the plasma membrane and intracellular membrane-bound intracellular organelles in the MPS-
mediated cell signaling in neurons. As the spectrin-actin based MPS structures likely exist in other differentiated
cell types such as lymphocytes and thereby control lymphocyte development and activation, our analyses will
also be extended to examine the role of the MPS in lymphocyte signaling during immune responses Our
proposed research will not only broaden our fundamental understanding of cell signal transduction controlled by
the membrane skeleton and the phase separation behaviors of signaling proteins in neurons and immune cells,
but also help suggest potential drug targets for human diseases including neurodegenerative diseases and
cancer.

Public health relevance
Project Narrative: While membrane proteins are important, constituting ~23% of the human proteome and more than 60% of current drug targets, little is known about how the cooperative action among different types of membrane proteins can be coordinated at the cell surface to precisely control the sensitivity and specificity of the downstream signaling. Our recent discovery has revealed a novel molecular mechanism by which a recently discovered spectrin-actin- based membrane skeleton structure can coordinate the interactions among major types of membrane receptors in neurons, giving rise to the downstream intracellular signaling. The goal of this proposed research is to reveal the distinctively physical molecular mechanisms by which this spectrin-actin-based membrane skeleton brings the selected groups of membrane proteins in proximity to form signaling protein complexes at the cell surface, and the results from the proposed research will not only deepen our understanding of how the subcellular compartmentalization of signaling proteins can be spatiotemporally controlled to dictate a specific signaling outcome, but also potentially inspire new strategies for the therapeutic intervention of human diseases.